Diversity Supplement to Study Treatment Engagement Among Minority Suicidal College Students

Abstract: Not required for supplemental submission. Federal Identifier: MH116061 Project Title: Research Supplements to Promote Diversity in Health‐Related Research

Public health relevance
Project Narrative: Not required for supplemental submission. Federal Identifier: MH116061 Project Title: Research Supplements to Promote Diversity in Health‐Related Research